Core 3 - DMSA Core

The Data Management and Statistical Analysis Core (DMSAC) will consist of two interacting components,[unreadable] the Data Management Center (DMC) and a Statistical Analysis Component (SAC).[unreadable] The specific aims of the DMSAC for the International Center for Research on Complementary and[unreadable] Alternative Medicine (ICRC) include the following:[unreadable] • Participate as collaborating investigators in the development and conduct of the three projects[unreadable] • Facilitate development of study protocols[unreadable] • Provide the infrastructure necessary to support the conduct, and monitor performance of, the[unreadable] studies[unreadable] • Design data collection and management systems and prepare and maintain study databases[unreadable] • Provide timely, expert interim and final statistical analyses of accumulated data[unreadable] • Participate in the preparation of scientific reports and manuscripts[unreadable] • Develop a data-sharing plan and respond to requests for data sharing[unreadable] • Develop a web-page to apprise the scientific community of data sharing availability and[unreadable] procedures[unreadable] • Coordinate the design, production, and maintenance of study and research group documents,[unreadable] such as study protocols, manuals of procedure, committee minutes, meeting notebooks[unreadable] • Serve as the official repository .of research group documents[unreadable] • Design and administer the research group websites[unreadable]